Academic Science Education and Research Training

Project Summary/Abstract
The Academic Science Education and Research Training (ASERT) program for postdoctoral scholars at the
University of New Mexico (UNM) matches PhD graduates from around the United States with outstanding
biomedical research mentors and engages New Mexico's diverse populations through effective science
education collaborations with minority serving institution (MSI) and national tribal college partners. As one of 24
NIH-NIGMS Institutional Research and Academic Career Development Awards (IRACDA), the ASERT
program requires scholars to spend 75% of their time on research and 25% on teaching and career
development activities. The overall, long-term objective of ASERT is to contribute to the number of junior
faculty across the country with the training and experience to succeed in all facets of academic life at
institutions that are likely to have highly diverse student populations and where interdisciplinary, collaborative
research is essential for success. To accomplish this goal, ASERT focuses on developing scholars with: 1)
strong, independent research programs through expert faculty mentoring teams, 2) preparation for effective
teaching and course and curriculum development that meets with success for diverse student populations, 3)
strong yet insightful leadership, mentoring, and management skills, and 4) team-building skills that underlie
success in the current job market. Additionally, the program aims to maximize reciprocal benefits of MSI
partnerships through development of effective role models and sharing of best teaching and research
practices. Based on unique demographics, ASERT aims to extend activities and programs proven to benefit
workforce diversification through expanded partnerships. Research training and most career development
activities take place at UNM and capitalize on the wide array and depth of available resources: research
seminars and journal clubs, participation in interdisciplinary research programs in cancer, bioengineering,
nanotechnology and clinical translational sciences, interactions with other NIH-funded programs for
undergraduates and post-baccalaureates (MARC, PREP, INBRE), highly relevant and internationally
recognized educational development workshops, education seminars and retreats, and skill- and team-building
activities. We will admit 4 scholars each year and have established a track record of fellows assuming
independent academic careers. All ASERT activities and career tracking are evaluated by a non-ASERT
evaluation team, collating feedback and input from ASERT scholars, and ASERT mentors to provide outcomes
data and assessment for continual program improvement.

Public health relevance
PUBLIC HEALTH RELEVANCY STATEMENT. The University of New Mexico Academic Science Education and Research Training program aims to increase the number of new college and university faculty. Trainees are prepared to excel in all facets of academic life at institutions likely to have highly diverse student populations. Training is achieved through: (1) conduct of cutting-edge research with scientists at the University of New Mexico, (2) career development and skill-building activities, and (3) practical teaching experiences at one of three partnered Minority Serving Institutions in New Mexico. Scholars contribute research-oriented, innovative teaching strategies, motivate students to participate in research, and nucleate collaborations.